PHASE II EVALUATION OF MGBG (NSC-32946) IN NON-HODGKIN'S PATIENTS WITH AIDS

This study is designed to examine the safety, tolerability and efficacy of MGBG on Non-Hodgkin's lymphoma in patients with AIDS.